Determining modes of dopamine transmission

Project Summary
Dopamine system is a key neuromodulator that plays multiple roles in regulating locomotion, activity and
motor learning within the striatum. As such dysfunctions in dopamine signaling arise in multiple
neurological disorders such as Parkinson’s disease. Despite a wealth of literature at the circuit, system and
behavioral level it still remains unknown how dopamine signals mediate transmission and how potentially
different signals drive different aspects of motor function and learning. To address this the current proposal
will use several novel approaches to examine if different dopamine signals exist and if they do what role
they may play in gross motor output and motor learning. By altering different aspects of dopamine release
and transmission this application will measure local receptor mediated signals as well as quantify bulk
spillover dopamine to determine if both aspects are equally perturbed by these manipulations. These
different animal models will also be used to see how these perturbations may alter different aspects of gross
motor output and motor learning. These experiments will test the central hypothesis that striatal dopamine
signals that underlie synaptic vs spillover can be independently regulated and that each regulate different
aspects of dopamine’s behavioral functions. The significance of this work will be to determine how
dopamine dynamics drive the activation of dopamine receptors to mediate transmission and to determine
how those dynamics directly participate in regulating striatal circuits to drive motor activity and motor
learning. The proposed studies are expected to be significant in that insights in to the specific mechanisms
that regulate dopamine transmission, and are expected to directly lead to testable hypothesis regarding the
dysregulations in this system that occur following the loss of dopamine in neurological disorders such as
Parkinson’s disease.

Public health relevance
Narrative Determining how dopamine signals participate in locomotor behaviors and motor learning is a key first step to understanding how this system becomes dysregulated in neurological disorders. A better understanding how dopamine release drives its actions will be significant and has the potential to direct new strategies for better therapeutics for diseases of the basal ganglia such as Parkinson’s disease.